Developmental Pathways to Borderline Personality Disorder: Longitudinal Observational, Clinical, and Neural Predictors From Early Childhood to Young Adulthood

PROJECT SUMMARY
Borderline Personality Disorder (BPD) is a prominent contributor to disability, burden, and
increased mortality. Although impairments in self (RDoC Systems for Social Processes:
Perception and understanding of self) and interpersonal (RDoC Systems for Social Processes:
Affiliation) functioning originate in early childhood, little is known about the developmental
psychopathology of these core features in BPD, as opposed to a related psychiatric disorder that
often precedes and co-develops with BPD: Major Depressive Disorder (MDD). The current
proposal will establish developmental trajectories of interpersonal and self dysfunction from early
childhood into young adulthood, examining interactions with environmental factors and
associations with aberrant neural circuitry, to predict onset of BPD in early adulthood. In this
renewal, we leverage 17 years of previously collected longitudinal data (R01 MH090786) from
348 young children enriched for emotional dysregulation. Now young adults (19-25 years), 36%
exhibit BPD above diagnostic threshold. This sample offers an unparalleled opportunity to
understand specific developmental precursors for BPD onset. Rich phenotyping, including over a
decade of clinical interviews, narratives, questionnaires, observations, and repeated MRI and
EEG assessments make this the ideal and highly cost-effective dataset to investigate impairments
in self and interpersonal functioning that lead to BPD versus MDD. New data collection in young
adulthood includes multi-method assessments of interpersonal and self functioning alongside
psychiatric diagnostic interviews. Our motivating hypothesis is that in the context of emotion
dysregulation, peer acceptance and aggression (interpersonal dysfunction) from preschool
through middle childhood, interacts with self-functioning (unstable, incoherent self-worth and self-
concept) in adolescence to uniquely predict BPD onset in adulthood versus MDD. We will
examine: (1) how specific aspects of these constructs prospectively relate to adult BPD, as
opposed to continuation of MDD; (2) during which developmental periods these constructs
provide the most predictive utility, including the moderating effect of specific environmental factors;
and (3) assess the predictive and mechanistic role of neural correlates of these constructs in
forecasting BPD versus MDD. Findings will inform the optimal timing and content-focus (i.e.,
specific neural/behavioral self and interpersonal targets) of novel early-intervention for preventing
BPD during the earliest developmental periods. This longitudinal research will be able to identify
risk factors for the persistence or worsening of interpersonal and self dysfunction and BPD onset,
offering the best starting point toward developing a prevention strategy for BPD.

Public health relevance
NARRATIVE Impairments in self and interpersonal functioning originate in early childhood and define Borderline Personality Disorder (BPD), yet we know little about how these constructs develop and interact across childhood and adolescence. This renewal will leverage 17 years of previously collected longitudinal data (R01 MH090786) to study the developmental origins of interpersonal and self dysfunction leading to BPD compared with MDD; combining this longitudinal data with newly collected observational, clinical, and personality indices during young adulthood. Results will have immediate implications for identifying risk trajectories unique to BPD onset, as opposed to homotypic continuity of MDD, starting at the earliest developmental points to inform the optimal timing and type of novel early-intervention targets for this strikingly impairing presentation.